Neural Correlates of Apathy Across the Alzheimer's Disease Continuum

Project Summary
Apathy is one of the earliest and most clinically distressing neuropsychiatric symptoms (NPS) in Alzheimer’s
disease (AD), whose neurobiology across the AD clinical spectrum is poorly understood. Although apathy can
be reliably measured by several validated scales and has been associated with clinical progression of AD, there
are currently few effective interventions for apathy or biomarkers of treatment response. Recently, the ‘mild
behavioral impairment (MBI)’ construct has been proposed to capture emergent, prominent NPS that may be
among the earliest presentation of underlying AD pathology in non-demented older adults, preceding or
coincident with cognitive impairment. MBI consists of 5 domains including a “decreased motivation, interest, and
drive” domain, capturing the reward circuitry and positive valence disturbance of apathy.
Despite the clinical relevance of apathy, a major research question is whether the disturbances in brain
circuits underlying apathy are shared with or different than those underlying cognitive and functional impairment
in AD, and whether these mechanisms vary through the behavioral and cognitive spectrum of AD. In the current
project, we will visualize the in vivo regional distribution of tau and amyloid and structural and functional brain
circuits (network connectivity and white matter abnormalities) to determine whether altered baseline brain circuits
and concurrent AD pathology predict baseline severity and future worsening of apathy across individuals with
the “full dimensionality of neurobehavioral functioning” (RFA-MH-19-510): 1) Cognitively normal (CN) older
adults, 2) amnestic mild cognitive impairment (MCI), 3) MBI-decreased motivation domain, and 4) mild AD
dementia. Attaining a better understanding of these neural mechanisms across early-stage AD is crucial for
developing new treatment strategies and biomarkers for clinical trials.
Our preliminary work investigating brain-behavior relations of apathy in AD has revealed evidence of early
inferior temporal and parietal involvement and later frontal-subcortical circuit alterations. Our experience with
flortaucipir positron emission tomography suggests that in preclinical AD, tau has an inferior temporal predilection
where it is also associated with depressive symptoms, while in MCI and AD dementia, there is wider spread,
including to frontal regions that are associated with apathy. We therefore hypothesize that as AD pathology
spreads and fronto-parietal circuits are disrupted, apathy will emerge and worsen.
We will assess the relationships among baseline measures of functional and structural brain circuits using
Connectome sequences, concomitant in vivo regional tau and amyloid pathology, and baseline and longitudinal
apathy over 3 years in 200 participants (50 CN, 50 MCI, 50 MBI-decreased motivation, and 50 mild AD
dementia). We will leverage funded R01 AG053184 (PI: Marshall) to cover imaging costs for CN and MCI
participants, while the current study will cover imaging costs for MBI-decreased motivation and AD dementia
participants, and apathy clinical assessment costs for all participants.

Public health relevance
Project Narrative Neuropsychiatric symptoms such as apathy are major manifestations of Alzheimer's disease (AD) with tremendous clinical relevance. However, the link between apathy in AD and the underlying pathophysiology remains to be explained—we do not know whether brain circuits underlying apathy are the same or different than other AD symptoms such as impairment in cognition and instrumental activities of daily living. This is crucial for understanding whether apathy is truly a prodromal symptom of AD and for developing critically needed treatments for apathy and biomarkers for clinical trials.